Insights into Coronary Microvascular Dysfunction in Diabetic Cardiomyopathy

Project Summary
Coronary microvascular dysfunction (CMD) is associated with coronary artery diseases (CAD),
diabetic cardiomyopathy (DCM), ischemia with the non-obstructive coronary artery (INOCA), and
HFpEF (heart failure with preserved ejection fraction). Patients with diabetes exhibit coronary
endothelial dysfunction, characterized by impaired acetylcholine-induced endothelial-dependent
relaxation. Impaired endothelium-dependent vasodilation (EDD) decreases coronary blood flow
and myocardium perfusion, leading to myocardial ischemia without an obstructive coronary artery.
However, the underlying mechanism of impaired coronary endothelial dilation in DCM is not fully
understood. Our preliminary study finds that NO is the mediator of endothelium-dependent dilation
(EDD) in small coronary arteries in healthy mice. However, in diabetic mice, we observe that
hydrogen peroxide (H2O2) is the principal endothelial-dependent vasodilator. Such a unique
preclinical diabetic model recapitulates a clinical observation of NO to H2O2 in CAD patients.
Moreover, we find a deficiency of miR-21 that restores the NO-dependent vasodilation in isolated
coronary arterioles of diet-induced diabetic mice. This application will address the functional
consequence of the miR-21-regulated NO to H2O2 switch in myocardial blood flow and cardiac
function and the underlying mechanism. We hypothesize that restoring “normal” coronary
microvascular function (restoring endothelial-dependent vasodilation) by modulating miR-21can
ameliorate diabetic cardiomyopathy (which is thought to be a disease related to impaired coronary
microvascular function). We will test our hypothesis by an interdisciplinary approach
encompassing a range of methods and disciplines from molecular and cell analyses and vascular
biology to physiology and pathophysiology, engendering the study of a novel mechanism of
coronary microvascular dysfunction, such as tissue-specific knockouts and lineage tracing with
3D fluorescent imaging, measurement of vasodilation and myocardial blood flow in vivo by
contrast echocardiography and cardiac function by echocardiography along with RNA-seq, sc
RNA-seq, etc. Completing this project may lead to a new strategy to treat microvascular
dysfunction and diabetic cardiomyopathy and improve the cardiovascular prognosis of diabetes.

Public health relevance
Project Narrative Relevance: Coronary microvascular dysfunction is associated with coronary artery diseases, diabetic cardiomyopathy, and HFpEF (heart failure with preserved ejection fraction). The current proposal is to study the underlying mechanism of a switch of mediator in endothelial-dependent vasodilation from NO to H2O2 in a pre-clinical diabetic model characterized by coronary microvascular dysfunction and how miR-21 regulates the switch and its consequence in myocardial blood flow in diabetic cardiomyopathy. We will establish novel therapeutic strategies to restore coronary microvascular function and stop the progress of diabetic cardiomyopathy.